Advancing biological and clinical applications of genomic Minimal Residual Disease detection in AML

ABSTRACT
Acute myelogenous leukemia (AML) affects more than 20,000 adult patients in the US per year causing greater
than 11,000 untimely deaths. Standard AML therapy comprises chemotherapy induction to achieve
leukemia debulking, followed by a few cycles of consolidation chemotherapy alone and/or followed by
allogeneic bone marrow transplantation. This general therapeutic approach to AML is risk-adapted relying
principally on well-established prognostic factors, including the type of AML, age, gene mutations and
cytogenetic results. Despite best efforts, AML remains incurable in the majority of afflicted patients. A
principle barrier to AML cure is disease relapse despite achieving a clinical complete remission (CR) following
standard chemotherapy regimens. Of substantial interest therefore, is the identification and accurate
measurement of residual AML that persists during remission in AML patients, as such residual disease is likely
the source of relapse. Several important questions about AML relapse are only in early stages of satisfactory
answers, including i) how to best measure minimal residual disease (MRD) in AML, ii) whether all MRD is
indeed caused by residual disease or rather as suggested by recent data comprises a mixture of leukemia, pre-
leukemia and age-related clonal hematopoiesis, iii) what constitutes the cellular source of relapse in AML, iv) if
such relapse-causing cells can be better targeted using novel therapeutic approaches, and v) under what
circumstances is MRD prognostic and useful for MRD risk-adapted AML clinical management.
Given lack of well-suited techniques to reliably answer the relevant questions detailed above, we have
optimized droplet digital PCR (ddPCR), a novel ultra-high sensitivity assay for detecting genomic MRD in
AML. In a detailed recently published study (Parkin et al, JCI 2017) we found that AML frequently relapses
from rare cells residing in remission marrows that based on mutation analysis resemble AML blast cells
detected at diagnosis. We demonstrated the feasibility for detecting AML-associated gene mutations at allele
frequencies as low as 0.002% and have also provided important novel prognostic insights.
In this application, we are proposing complete characterization of mutational MRD and aberrant cellular
clusters in AML remission bone marrows using a combination of sophisticated cell sorting and single cell
transcriptome analyses complemented with mouse xenografting and ex vivo colony forming assays. Anticipated
findings will improve the functional characterization of cells that carry AML-associated gene mutations in an
attempt to identify and better characterize the source(s) of AML relapse. Using AML samples from two clinical
validation cohorts, we will define the prognostic utility of ddPCR-based MRD assessments. Overall, data will
lay the foundation for future real-time genomic MRD-guided clinical AML trials aiming at monitoring and
improving consolidation and maintenance therapy and ultimately survival outcome in AML.

Public health relevance
Acute myelogenous leukemia (AML) affects more than 20,000 adult patients in the US per year causing greater than 11,000 untimely deaths. In this application, we are proposing the in-depth biological characterization of minimal residual disease in AML in complete remission bone marrows and association of mutant allele levels in these remission samples with remission duration and relapse rates. Resulting findings will likely guide the development of novel treatment approaches for this lethal leukemia.